Opponent control of action selection in the cortico-basal-ganglia-colliculus loop

Abstract
Action selection computations are at the core of goal-directed behavior. Models of action selection suggest that
appropriate actions are selected through competition between potential choice options. Choice competition is
thought to occur across a multi-regional network that span frontal cortex, basal ganglia, and their downstream
circuits where neuronal population encoding potential choice options mutually inhibit each other to provide
opponent control of choice activity. Yet, how these brain regions interact to mediate this process and the loci of
choice competition remain unresolved. We recently identified a frontal cortico-basal-ganglia-superior colliculus
network responsible for action selection of directional licking during decision-making. Distinct neuronal
populations in this multi-regional network encode opposing choice options for lick direction and exhibit push-pull
dynamics prior to a licking movement, reflecting choice competition. Remarkably, activating or suppressing the
superior colliculus is sufficient to bidirectionally control the push-pull choice competition dynamics within the
network, implicating the superior colliculus as a key network node that can mediate choice competition. These
data suggest a working model in which circuits within frontal cortex and basal ganglia encode competition choice
options and they influence downstream superior colliculus in a topographically confined fashion to drive opponent
control of choice activity for specific actions. Leveraging a suite of recently developed technologies, this proposal
aims to precisely define a mesoscale cortico-basal-ganglia-colliculus network for action selection (Aim 1 and 2)
and directly probe the interactions of frontal cortex, basal ganglia, and superior colliculus to resolve the loci of
choice competition (Aim 3). The outcome will test longstanding theories of action selection and elucidate their
neural circuit implementations.

Public health relevance
Research narrative The goal of the proposed research is an understanding of how action selection for goal-directed behavior is implemented in the frontal cortex, basal ganglia, and superior colliculus network. Malfunctions of this multi- regional network lead to repetitive and maladaptive behavior that affect a wide range of normal functions such as learning, motor skills, as well as social psychological well-beings. An understanding of the neural circuits that implement action selection could begin to outline a roadmap that informs treatments of these disease states.